GABA neurons in the ventromedial hypothalamus contribute to the counterregulatory response

Project Summary
Glucose is the primary fuel in the brain. Glucose-sensing neurons in the brain respond to glucose fall by
altering their firing activities, which trigger the counterregulatory responses to prevent severe hypoglycemia.
The ventromedial hypothalamus (VMH) is a critical component of neural networks that coordinate the
counterregulation. While the majority of VMH neurons are glutamatergic which have been well studied, a
small population of neurons in the ventrolateral subdivision of VMH (vlVMH) is GABAergic as they express
vesicular GABA transporter (Vgat). The functions of these Vgat neurons in the vlVMH (VgatvlVMH neurons)
have never been studied. We found that the majority of these are glucose-inhibited (GI) neurons. Since the
ionic mechanisms by which GI neurons respond to hypoglycemia are less defined, these GI-VgatvlVMH
neurons provide a unique opportunity to reveal the mechanisms and functions of a brain GI population.
Following our pilot observations, we will combine fiber photometry, electrophysiology, optogenetics, Patch-
seq, and CRISPR gene editing to test a general hypothesis that VgatvlVMH neurons represent a unique GI
population that are activated during hypoglycemia and critically contribute to the counterregulatory
response. The first objective is to establish the glucose-sensing functions of VgatvlVMH neurons in functional
animals and to further confirm their roles in regulating blood glucose levels. Second, we will determine if the
T-type voltage-gated calcium channel Cav3.2 mediates the glucose-sensing functions of GI neurons and
therefore regulate the counterregulation. Finally, we will identify VgatvlVMH-originated circuits that regulate the
counterregulation. The accomplishment of these studies may reveal the important functions of a novel neural
population that has never been studied before. We may also reveal ionic mechanisms for the glucose-sensing
functions of GI neurons. Further, we will delineate a new molecular target for brain glucose-sensing and the
counterregulation, which may provide a framework for the development of novel therapeutic strategies for
glycemic control.

Public health relevance
Project Narrative Brain glucose sensing plays a critical role in maintaining the blood glucose balance, but the underlying mechanisms remain to be fully understood. Here we will delineate the mechanisms by which a novel neural population in the brain can rapidly sense a glucose fall (hypoglycemia) and then prevent severe hypoglycemia. This study may provide a framework for the development of novel strategies to treat or prevent severe hypoglycemia.